The facts of the matter: decoding the molecular properties of brain white matter using cell-type-specific quantitative proteomics

Abstract
The brain is built from an elaborate network of interactions between neurons and non-neuronal
glial cells. Glial cells play active and essential roles in brain development and function, and glial
dysfunction is increasingly implicated in neurological disorders. However, we still have a
surprisingly limited understanding of the basic biology of most glial cell types and the
importance of glial cell crosstalk for proper brain function. This is particularly true in the brain
white matter, which comprises half of the volume of the human brain and possesses the highest
glia-to-neuron ratio of any brain region. In recent years, advances in single cell sequencing have
enabled a detailed study of the molecular and functional properties of neurons and glia in gray
matter brain regions. Unfortunately, substantial technical barriers currently impede our ability to
study the brain white matter and white matter glial cells at the same level of detail. Thus, our
understanding of the molecular and functional properties of white matter lags behind that of gray
matter, presenting a significant barrier to our understanding of healthy brain development and
function and our ability to treat neurological disorders. To overcome these technical and
scientific barriers, my lab will combine proximity-based in vivo quantitative proteomics with novel
viral tools to define the molecular landscape of the brain white matter with regional, temporal,
cellular, and subcellular specificity. We will perform these experiments in the healthy mouse
brain at different developmental time points, as well as in established disease models where
brain pathology is largely driven by white matter dysfunction. Ultimately, we will apply this
proteomic data to investigate specific molecular mechanisms of glia-neuron and glia-glia
crosstalk in brain white matter during brain development and disease, with a particular focus on
the interaction of two glial cell types: astrocytes and oligodendrocytes. These experiments will
provide an unprecedented window into the molecular architecture of the brain white matter and
address several critical gaps in our understanding of how half of the brain develops, functions,
and is impacted by disease.

Public health relevance
Project Narrative Dysfunction of white matter glial cells is a hallmark of many neurological and psychiatric disorders. We currently have a limited understanding of the molecular properties of white matter glia due to technical barriers. We will apply new tools to overcome these technical barriers and define the molecular landscape of the brain white matter during development and disease.